Immigration and Health

Abstract
The objective of our proposal is to investigate the causal effect of health insurance coverage on
healthcare utilization, health behavior, and health of immigrants living in the United States. We take advantage
of a policy-induced increase in insurance coverage of approximately 27% among non-elderly immigrants
between 2011-2013 and 2015-2018 and investigate its impact on a wide range of indicators of healthcare
utilization, health behavior, and health of immigrants. The Affordable Care Act (ACA) expanded Medicaid
eligibility to adults with incomes below 138% of the poverty line, but not all states complied with the federal law
and those that did differed in timing and degree of expansion prior to 2014. Our research strategy relies on the
increase in health insurance of immigrants resulting from the timing of expansion in Medicaid eligibility across
states.
Five key features distinguish our proposal from previous research: one, the increase in insurance we
study is much larger than those in previous research based on similar natural experiments. Two, we will cover
five years of the post-implementation phase for most outcomes. Extant studies on the effect of ACA on the
general population are based on data from one or two years after its implementation, therefore have failed to
capture long-term effects. Three, we will investigate if vulnerable groups, e.g. older, with chronic conditions
prior to ACA, were differently affected by health insurance coverage. Fourth, we will draw inferences on the
links between routine/preventive medical care use and extreme health outcomes such as emergency room
visits and hospitalizations. Five, we propose to use longitudinal data to identify more vulnerable populations
(e.g. those with preexisting conditions. Further, for several outcomes, we will use longitudinal data to follow the
same individuals pre-to-post ACA expansion and compare changes in medical care use (and health) of those
who experiened a change in insurance status to those who did not.
Our empirical analyses will be based primarily on three datasets: the National Health Interview Survey,
2011–2018; Medical Expenditure Panel Survey, 2011–2018; NHIS linked Mortality file, 2000–2016. ACA is
highly controversial and its impact on immigrant insurance coverage and healthcare use is widely criticized.
Yet, few scientific studies have measured its impacts on immigrants. Our proposed research will bridge this
knowledge gap and improve scientific knowledge of the impact of this landmark legislation on the well-being of
a highly vulnerable population.

Public health relevance
Narrative The proposed research will investigate the impact of insurance coverage on immigrants on their medical care use, health behaviors and health. These are issues with enormous fiscal and population health consequences. The knowledge generation by this research will help inform public health policy on how to improve the health of a large and growing segment of the US population and has implications for other vulnerable populations.